An Investigation of Focal Adhesion Tension During Cardiomyocyte Contraction

PROJECT SUMMARY
Cardiomyocytes sense macro scale mechanical cues to adapt their structure and function, and disturbances of
these mechanical signals can cause a negative feedback loop that leads to changes in cardiomyocyte structure
and ultimately decreased cardiac output. Important to this mechanical sensing are focal adhesions, the
mechanosensitive protein complexes that attach the cell cytoskeleton to the underlying extracellular matrix
(ECM). Although focal adhesions have been shown to be necessary for myofilament maturation and are sensitive
to external substrate characteristics, little is known about the specific forces sensed at these complexes during
the physiological contraction cycle or how this adhesive tension is regulated by cardiomyocyte contractility.
Furthermore, alterations of cardiomyocyte contractile tension initiate maladaptive cell remodeling, but this
mechanism and the involvement of focal adhesions are poorly understood. Given that focal adhesions of other
cell types have been shown to distribute focal adhesion tension unevenly within individual cells and
microdomains and that there are regional heterogeneities in cardiomyocyte strain, it is important to understand
the spatial distribution of mechanosensing in cardiomyocytes as the myofibrils contract against the ECM. This
proposal aims to fill the crucial gap in knowledge of the role of focal adhesions and their interactions with both
the myofibril structures and the ECM for the mechanical homeostasis of contracting cardiomyocytes. Previous
studies of focal adhesion sensation during contraction have been limited by the inability to measure exact force
across the focal adhesions in a time and spatially resolved manner. A recently developed tool that has been
used to study mechanically driven cell processes is the FRET (Förster Resonant Energy Transfer) tension
sensor, which I have engineered to express endogenously in induced pluripotent stem cells within the focal
adhesion gene vinculin. Preliminary data from stem cell derived cardiomyocytes that express this sensor show
myofibril contraction confers an increase in global focal adhesion tension sensation in static cells. However, the
spatial and temporal generation of force in cardiomyocytes during contraction is not yet known and will be
examined in this project using cutting edge microscopy and image analysis techniques. Importantly, this model
overcomes previous limitations of overexpression artifacts or inconsistent sensor expression. Thus, I propose to
first quantify spatial and temporal physiological focal adhesion tension during static and dynamic cardiomyocyte
contraction. Second, I will modulate both the inherent contractility of cardiomyocytes and their connection to the
ECM to determine the internal and external regulation of focal adhesion tension in cardiomyocytes. These aims
will provide a complete understanding of focal adhesion tension generation during CM contraction. This
understanding may inform future studies to develop better targeted therapies to maintain mechanical
homeostasis in heart disease.

Public health relevance
PROJECT NARRATIVE Cardiomyocytes sense internal and external physical cues to regulate mechanical homeostasis during the force generating cardiac cycle, and the focal adhesions are mechanosensitive structures that are important for both cardiomyocyte attachment to the extracellular matrix and maturation of the contractile apparatus. However, little is known about the specific spatial distribution of tension generation across the focal adhesions during cardiomyocyte contraction and the dependence of this tension on inherent cardiomyocyte contractile ability. This work seeks to utilize cutting edge molecular force sensor technology in stem cell derived cardiomyocytes to (1) study the spatial and temporal physiological focal adhesion tension during static and dynamic cardiomyocyte contraction and (2) determine the internal and external regulation of focal adhesion tension in cardiomyocytes through modulation of the contractile force and substrate attachment.